Integrative Physiology of Aging Training Grant

PROJECT ABSTRACT
This application is a renewal of our aging-related Integrative Physiology of Aging T32, which is currently in
its 20th year. The overall objective is to continue research training efforts on both the University of Colorado
Anschutz Medical Campus (CU-AMC) and the University of Colorado-Boulder Campus (CU-B). As with the
previous funding cycle, the major participating programs will be the Division of Geriatric Medicine (DGM), the
Department of Integrative Physiology (IPHY) at CU-B and the VA Eastern Colorado Geriatric Research,
Education, and Clinical Center (GRECC). Because we are the only T32 out of 50+ institutional training grants
(T32, TL1, KL2, K12) at CU-AMC/CU-B that specifically focuses on aging physiology, we are requesting
support for 5 predoctoral and 5 postdoctoral trainees each year, similar to the previous award. The specific
objectives of this training program are to continue to: 1) expand the participating faculty and create an even
more collaborative and effective mentoring group in support of age-related research at CU-AMC, CU-B and
Eastern Colorado GRECC; 2) recruit, select, support and retain high quality predoctoral and postdoctoral (MD
and PhD) trainees, with a continued emphasis on attracting underrepresented minorities (URM), women,
disabled, and individuals from disadvantaged backgrounds; 3) support experiential and didactic research
training opportunities in the integrative physiology of aging, including methods for enhancing reproducibility
(e.g., consideration of Sex as a Biological Variable); 4) support the “T-shaped Team Training” (T3) program for
trainees (and mentors); 5) monitor, support and ensure successful progress of trainees using predetermined
milestones, defined in their individual Career Development Plan (CDP); and 6) enhance the mentoring skills of
junior “associate mentors” through co-mentoring with a “primary mentor” and participation in the T3 program.
These objectives will be carried out by offering: 1) up to 2 years of research training support (the second years
dependent upon successful progress); 2) dual mentoring by outstanding primary and associate mentors; 3) a
variety of relevant classroom/research experiences on both campuses and team science training programs; 4)
frequent and careful review of trainee progress/success; 5) ongoing appraisal of the program goals, strength
and weaknesses; and 6) sound financial and administrative oversight. Our previous success is demonstrated
by our ability to: 1) fill all of our positions with outstanding trainees; 2) produce academically successful and
productive trainees; 3) build a pipeline of mentors, by transitioning trainees to associate mentors and associate
mentors to primary mentors; and 4) expand aging-research across campuses through ongoing collaboration
among the participating programs and faculty.

Public health relevance
PROJECT NARRATIVE The Integrative Physiology of Aging T32 will train the next generation of MD and PhD scientists to better understand and study ways to keep people healthy as they age. The T32 stresses: 1) co-mentoring trainees by primary and associate mentors; 2) individualized career development plans; and 3) team science training.